NASEM Task: EXAMINING THE LONG-TERM MEDICAL AND ECONOMIC IMPACT OF ANTIMICROBIAL RESISTANCE IN THE UNITED STATES

This task order will enlist an expert committee to examine and quantify the long-term medical and economic impacts of increasing antimicrobial resistance in the United States. The study shall examine progress made on the U.S. National Strategy and Action Plan for Combating Antibiotic-Resistant Bacteria, including domestic and international strategies employed by NIH, CDC, FDA, ASPR, USDA, and USAID.